Leadership Planning and Evaluation

PROJECT SUMMARY/ABSTRACT (LEADERSHIP, PLANNING AND EVALUATION)
The University of Michigan (U-M) Rogel Cancer Center (Rogel) has an effective and long-standing process for
leadership, planning and evaluation that engages Senior Leaders, Program Leaders, internal and external
leaders, Shared Resource (SR) Directors, Rogel members and staff. Rogel’s Senior Leadership is comprised
of nationally recognized, engaged experts who are strongly committed to the mission and vision of the Rogel
Cancer Center. Rogel Senior Leadership is intentional in establishing the membership of internal and external
advisory bodies to ensure diverse representation by gender, race, ethnicity, age, faculty rank (for internal
committees) and community, catchment area and national demographics (for external boards). Eric Fearon,
MD, PhD, is Director of the Rogel Cancer Center and Associate Dean for Cancer Programs in the U-M Medical
School. Fearon is supported by highly engaged, expert senior leadership and advisory committees. The Senior
Leadership Council (SLC), which meets weekly, is comprised of the Director, Deputy Director, and 11
Associate Directors. The SLC regularly engages with the Rogel Executive Committee (EC), comprised of SLC
and Research Program Leaders, Assistant Directors in COE and TrEC, SPORE leadership, the Emerging
Leaders Council Chair and Vice Chairs, senior advisors and communications. The EC meets monthly and
enables the SLC to discuss and jointly set priorities and future direction with PLs, as well as allows the PLs and
others to give feedback to the SLC on research progress and new developments. The Rogel External Advisory
Board (EAB) is a vital part of Rogel’s planning and evaluation process. The EAB, comprised of national leaders
with expertise in areas that align with Rogel’s Research Programs, SRs and components, meets at least yearly
and provides objective guidance and direction on Rogel’s strategic planning and initiatives. Rogel also
engages several internal and external advisory committees to provide objective oversight of SRs, TrEC, COE,
DEIJ, clinical research, and clinical services. Planning and Evaluation is essential to the cancer center’s
research mission and a regular part of the senior leadership’s activities. The 2022-2027 Rogel Strategic Plan –
Discovery to Cures to Communities – has six pillars: research; community outreach; education and training;
infrastructure and clinical research; Diversity, Equity, Inclusion and Justice; and patient care. The SLC, with
support from the EC, will lead the implementation and execution of the new strategic plan, as well as monitor
progress against goals, inform resource allocation, and make course corrections as necessary. These
processes and committees enable the SLC to promote: i) collaborative, transdisciplinary research across the
cancer research continuum to advance Rogel’s scientific innovations; ii) programs in training, education and
career development to empower the next generation of diverse cancer researchers and providers; iii)
community engagement, research and educational initiatives to address the cancer burden across the
catchment area and beyond; and iv) plans to enhance diversity across the Rogel community.